Improving cancer prevention and control through academic-local public health department partnerships

PROJECT SUMMARY
Background: The 2,800 local public health departments (LHDs) in the United States have been increasingly
responsible for implementing evidence-based programs and policies (EBPPs) to prevent and control cancer in
their local communities, which has immense potential to impact population-level cancer burden. Our team has
developed effective strategies to support LHDs and their staff to implement EBPPs, including guided facilitation
and training, but the reach and sustainability of these strategies is currently limited. A promising strategy is for
LHDs to engage in an academic-public health department (AHD) partnership, in which LHD practitioners and
academics collaborate to improve public health practice and education through joint research projects and
education opportunities for students. However, research on how AHD partnerships should be structured to
improve implementation of cancer-related EBPPs is sparse.
Goal: This proposal seeks to understand how to leverage AHD partnerships to facilitate implementation of
EBPPs to prevent and control cancer.
Methods: Aim 1: We will survey an existing, nationwide network of AHD partnerships to identify 4 high- and 4
low-performing partnerships based on their implementation of cancer-related EBPPs. We will use qualitative
interviews and document reviews to refine our existing set of strategies, which can improve the use of EBPPs
(e.g., facilitation needed, defining a tailored AHD partnership “package”), based on the structures, processes,
and contextual influences among successful partnerships. Aim 2: Building on Aim 1, we will test the
effectiveness of these refined strategies designed to improve the adoption of EBPPs for cancer prevention and
control by strengthening AHD partnerships. We will conduct a group-randomized study (total N=28 AHD
partnerships) to evaluate the effect of strategies to improve the adoption of cancer control and prevention
EBPPs by supporting AHD partnerships. A mixed-methods approach will be used to evaluate changes in AHD
partnerships and understand how contextual factors may have impacted the AHD partnership’s ability to
support EBPP implementation. We will translate and disseminate findings from Phases 1 and 2 to LHD
practitioners and academic partners to support cancer prevention and control in LHDs.
Innovations and impact: The proposed study is innovative and impactful because it will be first study to focus
on local-level collaborations that leverage expertise of LHDs and academics to improve public health practice.
Also, its application of bridging factors, a component of the Exploration, Preparation, Implementation, and
Sustainment (EPIS) framework receiving a greater focus recently, will contribute to the application of emerging
components of theoretical frameworks in dissemination and implementation research. Last, this study
examines new models for how public practice and academic public health can work together to meet common
goals sustainably, i.e., without ongoing support from outside researchers.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health because it addresses the implementation of evidence-based programs and policies (EBPPs) to prevent and control cancer within local communities across the US. Developing effective strategies to encourage local health departments’ (LHD) use of EBPPs in an ongoing manner is critical to the potential of these programs and policies to reduce burden, such as by leveraging the expertise of LHDs’ existing, local-level partnerships with academics. A project on the scale proposed has the potential to begin to shift the paradigm on how research can be quickly and effectively translated to those in the best position to use the evidence, such as LHDs.